TISSUE SPECIFIC REGULATION OF LIPOPROTEIN LIPASE BY INSULIN

Studies in insulin, glucose regulation of adipose tissue lipoprotein lipase in lean and obese subjects. Effects of nutrition and weight loss are assessed.